State-of-the-Art Synthesis of Interventions to Promote Quit Intentions and Smoking Cessation

Project Summary
Most people who smoke have no intention of quitting in the next 6 months or beyond, which begs critical
questions of the field of cancer prevention and control: How can tobacco cessation be promoted among these
smokers? What are the best ways to increase quit intentions? And how effective is changing quit intentions in
promoting smoking cessation? Despite the conceptual and practical importance of these questions, we lack
evidence-based answers – because a comprehensive test of the effectiveness of the hundreds of trials on quit
intentions and smoking cessation has yet to be undertaken. This project is a novel research synthesis that is
designed to answer these questions. In Aim 1, we will meta-analyze ~400 randomized controlled trials to (a)
discover how effective are interventions in promoting quit intentions, and (b) quantify the impact of changing
quit intentions on cessation rates. In Aim 2, we will determine what are the “active ingredients” of interventions
that lead to increased quit intentions and successful smoking cessation. We will contact trial authors to obtain
the original program materials and code the behavior change techniques that were deployed using the
Behavior Change Technique Taxonomy–v1 (Michie et al., 2013). For each randomized trial, we will also code
features of the sample, methodology, measurement of intention, and intervention (e.g., number of sessions,
duration, mode and source of delivery, use of pharmacotherapy, risk of bias) and assess associations with
effect sizes. A novel analytic strategy called Iterative Meta-Regression Analysis will be used to model how
behavior change techniques and other modifiable intervention strategies (e.g., delivery mode, intensity)
combine to generate the largest changes in quit intentions and the greatest improvements in cessation rates.
The project will offer a landmark synthesis of research on smoking cessation that quantifies the effectiveness
of interventions in promoting quit intentions and transforming quit intentions into smoking cessation – and
specifies ‘what works.’ Moreover, in Aim 3, we will generate a database of effective, research-tested program
materials that researchers, policy makers, and practitioners can access via the project website
(www.SmokingCessationTrials.info). Our project will thus offer a theoretically based and empirically derived
roadmap for future research and practice that contributes to reducing the leading cause of cancer.

Public health relevance
Project Narrative This project will synthesize findings from randomized controlled trials to discover how effective are interventions in promoting quit intentions and transforming quit intentions into smoking cessation. Our findings will shape future research and practice by ascertaining ‘what works’ in smoking cessation trials and by making research-tested, effective program materials accessible via the project website (www.SmokingCessationTrials.info).